Applying Mixed Methods to Identify Links between Cannabis Use and Sleep Behaviors with Ramifications for Veterans Clinical Health Outcomes

Veterans’ rates of sleep disorders have been increasing over the past 20 years, and millions report shorter than
recommended sleep durations for optimal sleep health. Contemporaneously, ongoing cannabis legislation in the
U.S. has increased access to, and availability of, cannabis products distinct by mode, formulation, and
cannabinoid composition. Moreover, as cannabis’ perceptions of harm are declining, widespread beliefs about
its therapeutic benefits are increasing and cannabis use disorder (CUD) remains prevalent. For example, one of
the most common reasons Veterans use cannabis is for sleep. However, cannabis’s effect on sleep is unclear,
likely due to a reliance on self-reports, cross-sectional data, and insufficient attention to cannabis product type.
Laboratory studies also administer cannabis with limited cannabinoid profiles and lower potency compared to
commercially available products used for sleep in the real-world. Equally important, cannabis/sleep research has
not adequately prioritized Veterans as prior findings come almost exclusively from civilian populations.
Smartphone apps and wearable technologies are valuable and unobtrusive tools to generate fine-grained data
on substance use and health behaviors. These technology-based-tools (TBTs) have considerable promise to
help understand how cannabis and sleep are related and identify potential prevention and intervention targets
tailored to Veterans. As such, the primary research objective of this Career Development Award-2 (CDA-2) is
to prospectively examine bi-directional relations between cannabis and sleep among non-CUD-treatment
seeking Veterans in the natural environment. Participants will first complete a 30-day pilot study by wearing a
Fitbit device and using an EMA app on their smartphone to measure cannabis use and sleep in the field followed
by individual interviews to determine protocol feasibility, acceptability, and adherence (Phase I, Aim 1). After
refining the study procedures based on results from the prior phase, Phase II research will evaluate bi-directional
links between cannabis use and sleep physiology/behaviors during a 30-day observational field period (Aim 2.1),
explore participants’ lived experiences using cannabis for sleep (Aim 2.2), and determine which specific cannabis
modes, formulations, or cannabinoid compositions are most harmful (or helpful) to self-reported and technology-
derived sleep behaviors (Aim 2.3).
Dr. Berey has demonstrated considerable scholarly productivity with an established track record of using different
TBTs in substance use research. This CDA-2 proposal aims to accelerate Dr. Berey’s training in cannabis and
sleep using TBTs, and to launch his VA-based research program. A collaborative and coordinated mentor team
will facilitate his successful transition to independence via training in: 1) EMA and wearable technologies (Drs.
McGeary and Merrill), 2) cannabis use among Veterans (Dr. Metrik), 3) measurement and core components of
sleep (Dr. Carskadon), and 4) advanced analytic techniques for longitudinal data (Dr. Merrill). This award offers
protected time that will allow Dr. Berey to engage in diverse training activities to strengthen his mixed-methods
research skills that he will use to identify optimal prevention and intervention targets for Veterans with sleep
problems and who use cannabis. Dr. Berey’s mentorship team consists of VA clinician scientists and non-VA
researchers with considerable expertise in areas germane to this CDA-2 proposal. The proposed mentors are
ideal candidates to facilitate Dr. Berey’s career goal of becoming an independent, VA-based scientist whose
research will have high public health impact by helping to improve Veterans’ clinical outcomes. Findings from
the CDA-2 will address a critically important gap in our understanding of how cannabis and sleep are related and
provide foundational data for subsequent VA Merit proposals.

Public health relevance
VA sleep medicine clinics exceeded 720,000 patient visits in 2018, and Veterans continue to have high rates of sleep disturbances and insomnia disorders. Rapidly expanding legislation in the U.S. has engendered widespread beliefs about cannabis’ therapeutic benefits, and Veterans often use cannabis for sleep despite equivocal evidence supporting its efficacy. Moreover, it remains uncertain which cannabis modes, formulations, or THC:CBD ratios are most harmful (or helpful) to sleep. This CDA-2 application will implement an innovative approach using different technologies to assess Veterans’ cannabis use and sleep over time, and in the natural environment. Results from this proposal and subsequent grants extending those findings will address a crucial knowledge gap concerning bi-directional links between cannabis, subjective sleep quality and sleep physiology (e.g., efficiency). Implications of this new knowledge cannot be overstated as sleep and several mental health issues common to Veterans (e.g., cannabis use disorder) are inextricably intertwined.